Building an unbiased pooled cohort for the study of lifecourse social and vascular determinants of Alzheimer's Disease and Related Disorders

SUMMARY
The prevalence of cognitive decline and Alzheimer’s Disease and Related Dementias (ADRD) is
socially patterned, with populations of lower socioeconomic status being disproportionately burdened
by these conditions. While there has been much research examining the contribution of education to
cognitive decline and ADRD risk, comparably less research has focused on income as a risk factor for
cognitive decline and ADRD. Even less research has examined the association of income over the
lifecourse with these outcomes. This is because most cohorts with an explicit focus on aging and age-
related outcomes recruit participants in mid or late life. In addition, the paucity of research may be due
to indicators of material wealth, such as income, being difficult to correctly measure and track over time.
The parent grant addresses this research gap by using an innovative data pooling method to create a
synthetic cohort. The synthetic cohort combines data from eight different cohort studies that, together,
span the lifecourse. However, the parent grant’s pooling method is yet to be validated with real-world
data. Furthermore, much of the research examining income’s contribution to cognition has utilized self-
reported income, which may be subject to inaccurate recall. In this diversity supplement, we will use
Social Security Administration (SSA) income data that is linked to Health and Retirement Study (HRS)
participants to validate the lifecourse income measures generated from the parent grant’s pooling
method. The SSA data will provide us with valid and accurate adulthood to retirement income data for
HRS participants, while the synthetic cohort will pool self-reported income data from the HRS (cohort
with income data from mid to late life) and the National Longitudinal Survey of Youth (NLSY; cohort
with income data earlier in life). Our specific aims are to: (1) Compare HRS participants’ actual and
accurate income data from the SSA to self-reported income data pooled across NLSY and HRS
to cover early adulthood to retirement ages, and (2) Examine the relationship of income
trajectories from adulthood to retirement with cognition, dementia and all-cause mortality using
HRS-SSA linked data and, separately, pooled income data from the NLSY and HRS. This project
will be doubly informative: validation of the parent grant’s pooling method will inform future approaches
to lifecourse research for ADRD as well as other disease areas; additionally, the outcome analysis will
robustly examine the association of lifecourse income trajectories with ADRD. Moreover, this project
will provide the applicant with training in social epidemiology, causal inference, and data pooling as
these areas related to ADRD research, which will increase his research capability and enhance diversity
in the field of aging research.

Public health relevance
NARRATIVE The contribution of lifecourse income to late life risk for Alzheimer’s Disease and Related Dementias (ADRD) is not known. The parent grant will tackle this research gap by creating a pooled, synthetic cohort with data that spans the full lifecourse. This diversity supplement research project will validate the parent study’s pooling method using valid and accurate income data from the social security administration (SSA) data linked to the Health and Retirement Study (HRS). Furthermore, this project will evaluate the association of lifecourse income data from the SSA and, separately, the pooled, synthetic cohort with cognition, ADRD risk, and mortality.